Project 2

ABSTRACT RESEARCH PROJECT 2
Research Study 2 is integrated into the TRANSFORM Center to promote the next generation of research on
child maltreatment, translation of research findings into clinical and preventive interventions, and dissemination
of research and practice knowledge/skills to varied stakeholders. The research is informed by a developmental
psychopathology perspective, incorporating multiple levels of analysis within a lifespan framework. Child
maltreatment frequently results in serious adverse consequences to diverse psychological and biological
systems in the course of development that have long-term detrimental effects on physical and mental health.
Thus, increasing knowledge of the mechanisms through which child maltreatment impacts health and well-
being, and advancing effective interventions, are of crucial public health significance. Project 2 evaluates the
long-term consequences of child maltreatment on adult physical and mental health through longitudinal follow-
up of individuals initially assessed in childhood during adulthood. The follow-up will include a randomly-
selected sample of 600 individuals aged 21-44 years from a larger existing sample. During school-age years,
these adults participated in research at Mt. Hope Family Center, and comprehensive measurements of diverse
aspects of maltreatment since birth were obtained, providing a more in-depth coverage of maltreatment
experiences than adult retrospective self-report. Multi-domain, multi-informant measurements of childhood
adaptive/maladaptive functioning were assessed, including childhood measures of cortisol regulation, providing
a rare opportunity to evaluate models of long-term predictors of adult mental and physical health. In adulthood
a comprehensive battery of measures from participants will be obtained. In addition to current life status, we
will assess cumulative life stress and history of trauma, as well as personal adaptive resources, i.e., self-
efficacy, self-esteem, emotion regulation, personality. Cortisol regulation will be obtained through hair samples
and in-home saliva samples. Anthropometric and cardiac measurements will be obtained as well as multiple
biomarkers and immune functions assessed via blood samples. Blood draws will also provide DNA to
determine targeted genotypes and epigenetic modifications. Finally, physical and mental health will be
assessed by structured interviews and questionnaires. Analyses will evaluate long-term consequences of child
maltreatment on cumulative stress, personal resources, allostatic load, epigenetic modifications, and physical
and mental health outcomes. We also will evaluate developmentally how earlier quality of childhood adaptation
and cortisol regulation may mediate adult outcomes, and genetic and epigenetic moderation of these
mediational processes. This work will provide the foundation for the next generation of advances in child
maltreatment research and insight into new prevention and intervention targets.